Defining molecular mechanisms by which stimulant evoked dopamine drives inflammation and neuronal dysfunction in neuroHIV

The HIV pandemic is increasingly driven by the spread of infection in vulnerable sub-populations with a relatively
high prevalence of substance abuse disorders (SUD), including the use of stimulants such as Methamphetamine
(Meth) and Cocaine (Coc). Stimulant use accelerates systemic disease, and can drive changes in
neuropathogenesis, increase risk neuropsychiatric comorbidities and accelerate cognitive decline, despite
effective ART. Despite the high prevalence of stimulant use among PLWH, the mechanisms by which stimulants
impact disease progression are poorly defined. This is particularly true in the CNS, as there are substantial
technical challenges involved in modeling microglial infection and interaction with neurons, as well as the
subsequent changes that this has on neuronal function. All stimulants increase CNS dopamine release, exposing
myeloid populations to highly elevated dopamine levels. Data indicate that it is the exposure to released
dopamine, rather than the stimulants themselves, which drives changes in microglial infection and function. Our
data support this, showing stimulant induced dopamine levels increase HIV entry and enhance myeloid
inflammation, increasing cytokine release, and NF-κB and NRLP3 inflammasome activity in vitro and in the NHP
CNS. Neuroinflammation driven by infected CNS myeloid populations is central to HIV neuropathogenesis in the
ART era, underlying the neuronal dysfunction and disruptions in neuroimmune communication that lead to
cognitive impairment and behavioral changes. We hypothesize that stimulant use exacerbates HIV-
associated microglial inflammation through dopamine receptor activation, leading to neuronal
dysfunction in neuroHIV. To address this, we propose to develop tractable, syngeneic co-cultures of human
iPSC-derived microglia (iMG) and iPSC-derived dopamine neurons (iDAN). Critically, these iDAN will release
dopamine in vitro in response to stimulant exposure. Co-cultures will be based on our existing protocols for iMG
and iDAN differentiation and will be developed and optimized for high-throughput analysis during the R61 phase.
During the R61, we will infect with HIV and treat with stimulants +/- ART, then use high content imaging, single
cell RNA-seq / ATAC-seq and Alphalisas to evaluate changes in viral dynamics (Aim 1b), gene expression and
chromatin accessibility (Aim 1c) and inflammation pathways (NF-κB, AP-1, STAT and NLRP3 activity, Aim 1d).
Using the R61 results as readouts, the R33 phase will use pharmacologic inhibition and CRISPR to identify the
specific dopamine receptors involved in each readout (Aim 2), and to examine neuronal function and
neuroimmune interaction (Aim 3) by evaluating; resting membrane potential and neuron firing rate with patch
clamp electrophysiology, dendritic spine density and morphology and microglial-neuronal contacts using
confocal imaging and Neurolucida360 analysis, and neuronal network activity using multielectrode arrays. This
will define specific dopamine receptors and microglial or neuronal functions that can be targeted to ameliorate
the impact of SUD on inflammation in PLWH by manipulating dopaminergic activity.

Public health relevance
An increasing number of people living with HIV use stimulants, such as Methamphetamine and Cocaine, but the cellular and molecular mechanisms by which stimulants interact with HIV and anti-retroviral therapy (ART) to drive neuroinflammation and promote neuronal dysfunction and neurocognitive impairment are poorly understood. We propose to resolve this knowledge gap by creating a consistent, translationally relevant, human cell-culture model of microglia and dopamine neurons that can release dopamine, enabling precise evaluation of the effects of both stimulants and stimulant-mediated dopamine release in the context of HIV and ART. Combining this system with our existing high-throughput assays, we will define the processes by which stimulants alter HIV infection and inflammation, identifying the genes, inflammatory pathways and receptors associated with these changes in both microglia and neurons and determining how these changes alter neuronal function and microglia-dopamine neuron communication.